CD8 T cell fate decision instructed by IL-2

Abstract
In response to viral infection or vaccination, antigen(Ag)-specific CD8 T cells that are present at low
frequencies undergo rapid clonal expansion. While the majority of activated CD8 T cells become terminally
differentiated effector T (TEFF) cells following expansion and die after Ag clearance, a small fraction of them
persists as memory cells (TMEM) that contribute to long-term protection. However, it remains incompletely
understood how cell-extrinsic stimuli through TCR and cytokine receptors establish the gene regulatory
networks that determine the fates of activated CD8 T cells. The overall goal of this grant is to dissect the
molecular and cellular mechanisms by which TCR and IL-2R signaling cooperatively regulates CD8 T cell
differentiation through the control of the critical transcription factor TCF-1 encoded by Tcf7. We will test the
hypothesize that cooperative action between signals induced by antigen and IL-2, but not IL-15, specifically
during priming induces expression of a set of transcription factors and epigenetic changes at a transcriptional
silencer element in the Tcf7 locus. The establishment of stable Tcf7 repression requires the stimulation-
responsive enhancement of IL-2R signaling, which establishes steady the TEFF- or TMEM-specific gene
regulatory circuitry that can be stably maintained after the inducing cell extrinsic stimuli decays as immune
responses resolve or become equilibrated. These studies will provide insights into the long standing question
of the molecular mechanisms of CD8 T cell differentiation and potential application to programming improved
immunotherapies.

Public health relevance
Project Narrative Cytotoxic CD8 T cell responses are required for host protection against intracellular pathogens and cancers. Differentiation into memory cells is required for long-term protection as well as sustainable response to tumors. We will dissect the mechanisms by which cell-extrinsic stimuli through TCR and cytokine receptors shape the memory differentiation program at genetic and epigenetic levels.